Identifying the mechanisms behind non-apoptotic functions of mitochondrial matrix-localized MCL-1

PROJECT SUMMARY
Aberrant regulation of apoptosis is a hallmark of human pathologies, including neurodegeneration, autoimmunity,
and cancer. Intrinsic apoptosis is regulated by the BCL-2 family which is composed of anti-apoptotic proteins
(e.g., BCL-2 and MCL-1) which sequester pro-apoptotic BH3-only proteins (e.g., BIM and BAD) or directly inhibit
pro-apoptotic effectors, BAX and BAK, preventing their oligomerization. Many cancer cells overexpress anti-
apoptotic proteins to promote aberrant survival. MCL-1 is unique among anti-apoptotic proteins because it is
essential in early embryonic development and for the survival of many cell lineages (e.g., hematopoietic stem
cells, lymphocytes, neutrophils, neurons, and cardiomyocytes). Our lab previously reported that MCL-1 has two
isoforms –– one that localizes to the outer mitochondrial membrane (OMM) and one that localizes to the
mitochondrial matrix. Although OMM MCL-1’s canonical anti-apoptotic function has been well characterized, the
roles of matrix MCL-1 are still largely unknown. Evidence suggests that matrix MCL-1 serves to maintain normal
mitochondrial fission/fusion, oxidative phosphorylation, and cristae ultrastructure. The basis for these physiologic
roles of MCL-1 remains unknown. Metabolomic investigation of Mcl1–deficient (Mcl1–/–) murine embryonic
fibroblasts (MEFs) and MEFs lacking matrix-localized Mcl1 revealed that they are highly sensitive to glutamine
deprivation as compared to wild-type MEFs. Additionally, MCL-1 protein levels decrease after 24 hours of
glutamine withdrawal in wild-type MEFs. These data suggest a link between MCL-1 and glutamine metabolism
that could be connected to the mitochondrial defects that are observed upon Mcl1 deletion. The goal of this
proposal is to determine the functions of matrix MCL-1 and gain a mechanistic understanding of these functions.
I hypothesize that matrix-localized MCL-1 plays an essential, non-apoptotic role in maintaining
mitochondrial morphology and bioenergetics. To address this hypothesis, I will use a novel mutant mouse
that endogenously expresses a truncated MCL-1 protein (MCL-1OM) which blocks apoptosis but cannot be
imported into the mitochondrial matrix. First, I will ectopically express Mcl1 mutants back into Mcl1–/– MEFs to
determine which version(s) of Mcl1 can rescue the death triggered by glutamine withdrawal. I will also perform
mRNA-Seq on Mcl1–/–, Mcl1+/+, Mcl1–/+, and Mcl1–/OM MEFs to interrogate the metabolic rewiring induced by loss
of matrix-localized MCL-1. Second, I will assess mitochondrial function (e.g., Seahorse XF Mito Stress Test and
TMRE staining), determine the proteins interacting with matrix-localized MCL-1, ectopically express Opa1 and
Drp1 mutants in Mcl1–/– MEFs, and perform confocal imaging on these cells to determine the functions of matrix-
localized MCL-1 in mitochondrial morphology. Finally, I will perform in vivo experiments on Mcl1-/OM mice to
analyze T cell activation, effector function, and memory T cell generation. These findings will provide new,
mechanistic insights into the non-apoptotic roles of matrix-localized MCL-1 and could shed light on the potential
consequences of using MCL-1 inhibitors for clinical applications.

Public health relevance
PROJECT NARRATIVE Overexpression of the anti-apoptotic protein MCL-1 frequently occurs in both solid tumors and hematological malignances, which has inspired the use of small-molecule inhibitors of MCL-1 in clinical trials. MCL-1 has two distinct isoforms –– one that localizes to the outer mitochondrial membrane where it performs its canonical anti- apoptotic function and one that resides in the mitochondrial matrix where it regulates mitochondrial homeostasis through unknown mechanisms. This proposal aims to provide mechanistic insights into the non-apoptotic roles of mitochondrial matrix-localized MCL-1 and will shed light on the potential consequences of using MCL-1 inhibitors for clinical applications.